Functional evaluation of a new GWAS locus that links visceral adiposity and type 2 diabetes

Project Summary: The intertwined obesity and type 2 diabetes mellitus (T2D) epidemics have focused
attention on pathological changes in adipose tissue. However, obesity represents just one of several adiposity-
related phenotypes linked to T2D. Visceral fat storage independent of total fat mass is a predictor of T2D.
Moreover, there is an overlap in the underlying genetic architecture of T2D and adiposity phenotypes,
suggesting shared developmental pathways. In a recent GWAS meta-analysis, we discovered several novel
candidate genes linked to deleterious ectopic fat deposition, including the E2 ubiquitin ligase UBE2E2, a lead
candidate identified by its genomic proximity to non-coding SNPs associated with visceral fat. UBE2E2 has
also been identified by GWAS of T2D. This combined association with a metabolically deleterious body fat
distribution and T2D provided rationale to prioritize UBE2E2 for additional functional studies. We have now
demonstrated that excision of 100bp regions of non-coding DNA, inclusive of lead UBE2E2-associated SNPs,
attenuates expression of UBE2E2, that UBE2E2 loss-of-function in ex vivo adipogenesis assays dramatically
inhibits adipocyte differentiation, and that impaired glucose homeostasis arises in a mouse model of UBE2E2
loss-of-function. These preliminary data inform our central hypothesis: that genetic variation in non-coding
regions in the UBE2E2 locus results in partial UBE2E2 loss-of-function, impaired adipocyte development as
manifested by an obligate shift in favor of ectopic fat deposition, and predisposition to T2DM. We propose to
dissect the molecular and biochemical mechanisms underlying the GWAS signals with two interrelated specific
aims. In Aim 1, we will interrogate the UBE2E2 locus with Clustered regularly interspaced short palindromic
repeats (Crispr) genome editing. We will edit lead SNPs into human adipose derived stem cells and quantify
UBE2E2 expression and adipocyte differentiation. With a complementary approach, we will scan the UBE2E2
locus with a Crispr screen to identify putative regulatory regions and their proximity to disease-related SNPs.
We will also perform structure-function studies, mutating critical UBE2E2 functional domains, to characterize
the biochemical mechanism by which UBE2E2 regulates adipocyte development. Then in Aim 2, we will utilize
a murine model of UBE2E2 loss of function to test whether the human traits – visceral adiposity and T2D – are
recapitulated and moreover whether these phenotypes are attributable to a defect in adipocyte development.
Our laboratory has developed methods of precisely quantifying adipogenesis, in vivo, utilizing stable isotope
tracers and state-of-the-art mass spectrometric imaging, which we will utilize to quantify adipogenesis. We will
couple our quantification of adipogenesis with rigorous characterization of depot specific adiposity and
systemic metabolic profiling. Now that GWAS have identified large numbers of candidate genes, their
functional characterization is a major bottleneck. This project will establish a pipeline that can be broadly
applied to functional validation of variants related to fat phenotypes and cardiometabolic disease susceptibility.

Public health relevance
Project Narrative: Type 2 diabetes mellitus affects nearly 10% of the U.S. population. Abnormal fat development or function, independent of obesity, contributes to diabetes risk. This project will study the shared pathophysiological basis for abnormal fat development and diabetes through in depth genetic and biochemical studies of a candidate gene, UBE2E2, identified by genome wide association of non-coding variants with diabetes and with metabolically unhealthy visceral fat.